Development of an immune evasive stem cell line for Type 1 diabetes regenerative therapy

PROJECT SUMMARY
Type 1 diabetes mellitus (T1DM) is an autoimmune disease characterized by the destruction of insulin-producing
β-cells within pancreatic islets, culminating in dysregulated blood glucose levels, affecting 2 million Americans.
The standard of care for T1DM is continuous glucose monitoring and exogenous insulin therapy. Despite
significant advancements in insulin delivery methods, only 17% of children and 21% of adults achieve the
recommended HbA1c levels of <7.5 and 7%, respectively. Clinical islet transplantation (CIT), during which
allogeneic donor islets are injected into the portal vein, has successfully obtained 78% insulin independence;
however, CIT is challenged by allogeneic human cadaveric islet supply, graft failure, and the need for chronic
immunosuppression. Implantation of cadaver islets or stem cell-derived islets (SC-Islets) either unencapsulated
or surrounded by a semipermeable encapsulating membrane designed to be immune-protective is also being
explored but requires immunosuppression or presents the risk of fibrosis, respectively. None of the current
treatments have replicated native β-cell function; therefore, there is a critical unmet need for more efficacious
T1DM treatments.
Thus, Aleutian Therapeutics (Aleutian) is developing a novel cell therapy that addresses the limitations of
available treatment options for T1DM. Aleutian’s innovative novel technology involves the generation of
allogeneic islet-like organoids from pluripotent stem cells and gene modification to enable immune evasion upon
transplantation. Together, these innovations will alleviate the cell supply limitation and the requirement for
immune suppression treatment of current cell therapies. Aleutian’s academic collaborator has previously
conducted animal studies demonstrating: 1) the successful differentiation of stem cells into islet-like organoids
and glycemic control upon transplantation; and 2) the extension of cell survival following the introduction of
programmed cell death ligand 1, a known regulator of immune tolerance, in an immune-competent xeno mouse
model. However, these cells do not survive in the mice long-term due to xeno and allo immune rejection. Aleutian
therefore plans to develop a panel of edits targeting broad innate and adaptive immune compartments. The goal
of this Phase I study will be to show in vitro proof-of-concept of immune evasion with these edits and the ability
to differentiate into allogeneic islet-like organoids. We aim to produce and bank the gene-edited cell lines and
subsequently evaluate them for SC-Islet differentiation, in vitro function, and immune evasion in vitro. Successful
completion of the proposed Phase I study will show that engineered stem cell-derived islet-like organoids are
capable of glucose-stimulated insulin secretion while evading immune reactivity in vitro, which will inform Phase
II in vivo efficacy studies.

Public health relevance
PROJECT NARRATIVE Type 1 diabetes mellitus (T1DM) is an autoimmune disease characterized by the destruction of insulin-producing β-cells within pancreatic islets, culminating in dysregulated blood glucose levels, affecting 2 million Americans. None of the current treatments have replicated native β-cell function; therefore, there is a critical unmet need for more efficacious T1DM treatments. Aleutian Therapeutics is developing an innovative technology that involves the generation of allogeneic islet-like organoids from pluripotent stem cells and gene modification to enable immune evasion upon transplantation, alleviating the cell supply limitation and the requirement for immune suppression treatment of current cell therapies.